to UCSF’s Advocacy and Community through Empowerment Program

PROJECT SUMMARY/ABSTRACT
The rationale for this grant is rooted in the observed disparities in the experiences and
outcomes of UCSF students from historically underrepresented and marginalized (HUG) groups.
Despite being academically indistinguishable from their majority peers in terms of GPA,
publications, and time to degree, these students report higher rates of unhappiness and
dissatisfaction, leading to lower participation in the scientific workforce upon graduation. We and
others contend that the repeated emphasis on the negative experiences and unique difficulties
encountered by these students has created a deficit focused thread of inquiry in which research
continually identifies institutional mismatches and achievement gaps as compared to their well-
represented peers. Arguably, identifying deficits does not account for the positive experiences
and successes of these students, nor acknowledge that there are many historically
underrepresented and marginalized students who elect and successfully complete higher STEM
degrees, pursue STEM careers, or choose to use their STEM degrees in creative ways.
Therefore, this proposal is guided by evidence in graduate education that points to the importance
and effectiveness of social support programs that help HUG students successfully navigate the
graduate school experience.
The overarching mission of the proposed UCSF IMSD-T32 Program is to intentionally
cultivate a community that values the experiences and perspectives of each HUG cohort and
prepares fellows for academic and professional success as biomedical researchers. Training and
activities proposed here will help IMSD Fellows’ academic and career success, because they will
develop a strong sense of scientific identity through a series of co-curricular innovations that
promote better alignment between personal and professional values, thus strengthening IMSD
Fellows’ ability and desire to persist toward positions of scientific leadership. The program aims
to foster scientific identity congruence and create a supportive academic environment that centers
around community, belonging, identity, and organizational congruence. Key innovations include
summer research rotation opportunities with programming to align personal and professional
values, near-peer mentoring to foster mentorship skills, and initiatives to develop IMSD Fellows'
agency and ownership in academic and career planning. By reinforcing anti-deficit framework and
operationalizing campus resources for well-being, community building and career development,
the proposed UCSF IMSD-T32 Program will provide frameworks for IMSD Fellows to create and
measure their own pathways toward success.

Public health relevance
PROJECT NARRATIVE The diversification of U.S. scientific ingenuity is essential to the enrichment of both the talent engaged in and the quality of scientific research produced by the biomedical enterprise. The UCSF IMSD program will foster the diversification of the next generation of scientific leaders by establishing a welcoming and inclusive community that strengthens their sense of scientific identity through rigorous academic preparation, the conscious alignment of personal and professional values, and professional and leadership development to promote persistence towards positions of leadership in the biomedical workforce.